Measurement of glucose homeostasis in human brain by NMR

Impaired awareness of hypoglycemia (IAH), which is a diminished ability to perceive the onset of hypoglycemia
(HG) and typically co-exists with a reduction in the counterregulatory hormone responses (CRR) to HG, triples
the risk of experiencing potentially fatal severe hypoglycemia for patients with type 1 diabetes (T1D). Our long-
term goal remains to identify how recurrent HG leads to the clinical syndrome of IAH in T1D. Here we will
study the cerebral mechanisms of IAH in the setting of T1D following exposure to experimental recurrent HG
and test the hypothesis that recurrent HG in T1D leads to an upregulation in brain glucose transport
and alterations in glutamatergic and GABAergic tone. We will use MRS methodology that permits
evaluation of cerebral cortex and hypothalamus in the same session to simultaneously evaluate the cerebral
correlates/mediators of impaired awareness and impaired CRR. High MR data quality and reproducibility will
be ensured by using high field MR scanners and technical advances we made during the last grant cycle
(automated voxel placement, real-time voxel tracking, dynamic frequency and shim updates). Continuous
glucose monitoring and actigraphy will be used to chronicle glucose variability and activity/exercise/sleep
during the weeks before each experiment to assess the impact of these variables on IAH. Our specific aims
are:
Aim 1: To measure the neurochemical response to hypoglycemia in T1D (N=50) before and after
induction of IAH. Neurochemical profiles including glutamate, GABA and glucose will be measured in the
frontal cortex, a region associated with IAH in prior neuroimaging work, and in hypothalamus, which regulates
CRR, during euglycemia and HG at 7 tesla, at baseline and after a recurrent HG protocol that robustly induces
IAH in patients with T1D and NAH.
Aim 2: To measure cerebral glucose transport in T1D (N=50) before and after induction of IAH. Kinetic
parameters for glucose transport will be measured in the frontal cortex and hypothalamus using hyperglycemic
clamps at 3 tesla at baseline and after recurrent HG.
These experiments will establish if recurrent HG alters cerebral glucose availability and glutamate and GABA
tone in T1D and if these cerebral adaptations are associated with the development of blunted CRR and
diminished symptoms in patients with T1D. In addition, we will learn how glycemic excursions and
activity/sleep impact the induction of IAH. These observations are expected to lead to new ways to prevent and
treat this life-threatening condition in T1D.

Public health relevance
We aim to identify how recurrent hypoglycemia in diabetes leads to impaired awareness of hypoglycemia, a devastating problem that prevents patients from achieving optimal glucose control. We plan to use magnetic resonance spectroscopy to learn how hypoglycemia impacts the human brain to cause this syndrome.